Molecular and neural mechanisms associated with injury and recovery from traumatic brain injury

Optimal reward-guided behavior relies on intact connections between prefrontal cortex and striatum: circuitry
that is disrupted by frontal brain injury1,2. Sustaining a brain injury increases risk for developing depression,
anxiety, attention deficits, mood disorders and problems with impulse control3,4. The symptoms of frontal
traumatic brain injury (TBI) strongly resemble psychiatric disorders with regards to disruptions in reward-guided
behavior, and therefore may share common mechanisms driving behavioral impairments. Mechanisms may
include a combination of inflammatory, molecular, and cellular changes that are triggered by injury. Determining
which factors mediate persistent effects of behavior is necessary to understand chronic impacts of TBI and
develop treatments addressing the often debilitating symptoms enduring after injury. The proposed research will
examine how severe and mild frontal TBI impacts neural communication with its distributed striatal network to
influence reward-guided behavior. Identifying a neurophysiology signature associated with reward deficits would
provide a new target for brain-based treatment options. Neuromodulation, altering the electrical potentials of
the brain, may serve as a potential intervention to remediate behavioral deficits by restoring rhythmic brain
patterns and structural integrity of their underlying connections following injury. Preclinical testing in
translational animal models is critical to better understand the structural and functional mechanisms driving
behavioral impairments, and to test repetitive brain stimulation as a method to remediate effects of injury.
The first goal of this proposal is to quantify behavioral consequences of severe and mild frontal TBI made using
a controlled cortical impact (CCI) in rodents. TBI causes axonal shearing of white matter tracts and chronic
inflammation resulting in long-term changes to the brain’s microstructure. Abnormalities in corticostriatal
connectivity is being implicated in the onset of psychiatric-like symptoms, yet the relationship with TBI-induced
impairments remains unclear. As one of the most widely used injury models in animals, CCI produces focal
damage in rats that mirrors concussion, contusion, and hemorrhage in humans by driving an impactor directly
into the brain through a surgical opening in the skull30. The injury severity and location are controlled by the
experimenter and highly reproducible across animals. After injury, rats will perform a probabilistic reversal
learning task which requires reward-guided decision making, behavioral inhibition, flexible behavior, and
conditional discrimination: cognitive functions that all depend on intact prefrontal cortex. Reward-related
behavioral impairments on the reversal learning task will be related to microstructural changes.
To capture disturbances in the cortico-striatal network after TBI, brain activity will be recorded as rats run the
probabilistic reversal learning task. Neural activity is not random, it oscillates at periodic frequencies to coordinate
communication within and between distributed brain areas. Each of these frequency bands are predicted to
coordinate different aspects of behavior through long-range coupling in functional networks. Large-scale local
field potential probes will be used to record from 32 brain areas simultaneously capturing these oscillatory
dynamics during reward-guided behavior. Identifying frequency-specific activity that is disrupted by TBI, would
offer insight into the neural mechanisms of reward-guided behavior and point to a new therapeutic target.
Lastly, brain stimulation targeting the cortico-striatal network will be used to assess its effectiveness at inducing
neuroplasticity changes to remediate effects of TBI. We will follow neuromodulation procedures known to be
successful in humans with the goal of studying the structural and functional mechanisms associated with
restored reward-guided behavior. The proposal will examine if stimulation to lateral orbitofrontal cortex can
improve reward-guided behavior, restore cortico-striatal network activity, and induce long-term structural
changes. This research is critical to identify mechanisms of TBI and remediate reward-related impairments.

Public health relevance
Traumatic brain injury (TBI) impacts 1.7 million people per year in the United States5. TBI often results in chronic changes in cognition and mood that we cannot effectively treat3,4. The likelihood of sustaining a brain injury is increased for military personnel. 15-20% of soldiers serving in Iraq and Afghanistan experienced a TBI during deployment6. The proposed research investigates the brain mechanisms contributing to persistent cognitive deficits following frontal TBI. Preclinical models are necessary to employ invasive techniques to measure, manipulate, and restore brain activity that will ultimately inform human TBI research. The current proposal aligns with the VA’s mission to identify clinically relevant biomarkers used to predict patient outcomes and assess treatments for Veterans. New treatment options follow a precision medicine approach: targeting a specific brain area/function that is individualized based on each unique trauma. This research tests the effectiveness of precision stimulation to remediate cognitive behaviors after TBI by restoring brain activity through neuroplasticity.